Administrative Core

ABSTRACT
The Administrative Core is the supportive framework of the University of Washington Interdisciplinary Center
for Exposures, Diseases, Genomics, and Environment (EDGE) and provides the cohesion that ensure its long-
term success. The Administrative Core’s primary responsibilities include Center fiscal oversight, tracking
membership and achievements, encouraging communication and research translation through activities such
as creating and maintaining a Center website for members and broader audiences, planning and evaluation
activities, supporting the pilot project program, fostering collaboration and Center integration among members
and facility cores, and cultivating careers of early and mid-career investigators. By coordinating the meetings of
the Internal Advisory Committee and the External Science Advisory Board, the core will facilitate and monitor
the Center’s progress towards expected outcomes and make suggestions for adjustment, as needed. The
Center is based on a multi-disciplinary collaborative effort between investigators across multiple schools and
departments within the University of Washington, as well as the Fred Hutchinson Cancer Research Institute
and Seattle Children’s Hospital. Therefore, a highly integrated Administrative Core is vital to the success of the
Center. The Center puts special emphasis on cultivating the careers of the Center’s early and mid-career
investigators and the Administrative Core facilitates these activities. Emphasizing its commitment to career
development and mentoring, the Center supports Career Development Investigators (CDIs). The
Administrative Core will work closely with the Community Engagement Core (CEC) to foster Center integration
and perform career development, outreach, and research translation activities. Overall, the Administrative Core
provides management and oversight of the many functions that allow the Center to fulfill its mission to promote
innovative research, engage important EHS stakeholders in the region, and launch the next generation of
molecular signatures research and researchers. The Core does this by providing a supportive infrastructure
that encourages collaboration and creativity, builds capacity, and keeps lines of communication open.